Administrative Core

This core will provide support for administrative management and research coordination of the entire program project grant. Administrative support (management of personnel and fiscal matters) on an ongoing basis is required for the successful performance of this program project grant. Our program is an integrated multi departmental effort, which spans several disciplines. These include medical oncology, radiation oncology, pulmonary medicine, immunology, infectious diseases including virology, and pathology. The preclinical and clinical studies are contributed by scientists from these disciplines in each of the projects with support by the two cores of this grant application. Efficient integration of these efforts requires a major effort in coordination and collaboration. Core A is intended to optimize the interaction between all participating investigators. Administrative support includes also communication between the investigator and the institutional review bodies, external consultants, governmental review groups and NIH officials. Core A will serve to coordinate all efforts to maintain data accrual from referring physicians and from patients after discharge from the bone marrow transplantation unit, including longitudinal evaluations of recipients in an organized manner.